Identification of Lethal Melanomas at the Time of Diagnosis

PROJECT SUMMARY/ABSTRACT
Melanoma incidence rates continue to increase, whereas rates for most other cancers have
declined. Emerging systemic therapies for patients who have progressed to metastatic melanoma
are extending survival, but can be toxic, immensely costly and have variable efficacy. There are
efforts to extend the use of new agents to earlier disease stages as adjuvant therapies. Better
prediction of lethal melanoma at time of diagnosis is important to determine those who would
benefit from adjuvant therapies and, conversely, avoid toxicity in those whose melanomas are
unlikely to recur. Our central hypothesis is that it is possible to determine the combinations of
genetic alterations and immune responses in tumor samples that define a melanoma likely to be
ultimately lethal if not treated early. Conversely, we hypothesize that it will be possible to identify
somatic profiles of the tumors that indicate a very low risk of recurrence and ultimate death of the
patient, obviating the need for expensive, toxic treatments in such patients. We also hypothesize
that host characteristics, including germline variants in multiple genes, will be associated with
lethal melanoma. In Aim 1, we will test whether common somatic mutations in 104 genes/gene
regions in tumors are associated with death from melanoma. These genes include known
oncogenic drivers (BRAF, NRAS and TERT) and tumor suppressors (NF1, CDKN2A/CDKN2B,
PTEN and TP53). We will also test the hypothesis that measuring the immune cell milieu will add
information to survival prediction beyond conventional grading of tumor-infiltrating lymphocytes.
We will then explore how best to combine the genetic alterations, immune measures and 2018
American Joint Committee on Cancer (AJCC) tumor stage to identify those melanomas highly
likely to be ultimately lethal. In Aim 2, we will determine the extent to which the host characteristics
of germline variants, phenotypic characteristics, sun exposure, age and gender differ among
melanoma cases characterized as potentially lethal vs. nonlethal, leading to the identification of
a subset of the population at high risk for lethal melanoma. This research will be undertaken using
a resource that is uniquely suited to addressing these issues, the international, population-based
Genes, Environment and Melanoma (GEM) Study, which collected epidemiologic data, pathology
and tumor sections for a large cohort of incident primary cutaneous melanoma cases diagnosed
in the year 2000. We have available a minimum of 10 years of follow-up of vital status and cause
of death for all cases. GEM is an ideal resource because the end of the follow-up period precedes
the targeted and immune therapy era, allowing us to study factors affecting the natural history of
the disease. The vast majority of GEM cases (more than 85%) presented with local disease, and
we project that at least 80% of the deaths will occur in cases initially presenting with local or
regional disease. The results should enhance our ability to identify lethal melanomas at an early
stage when treatments may be more effective and, conversely, to identify melanomas with a very
low risk of recurrence for which unnecessary and potentially toxic treatments can be confidently
avoided.

Public health relevance
PROJECT NARRATIVE This project has the potential to change prevention paradigms and alter the staging and strategies for treating patients with newly diagnosed melanoma, a serious skin cancer that leads to approximately 10,000 deaths in the USA each year. The goal is to identify at the time of diagnosis which melanomas are the dangerous, potentially lethal ones that should be treated early and, conversely, which melanomas are very unlikely to lead to recurrence and death, potentially sparing these patients toxic and expensive treatments. We will accomplish this by examining the genetic and immune alterations in tumor samples collected from 1,690 patients diagnosed with melanoma in the year 2000 with 10-year follow-up, allowing us to determine which combinations of tumor alterations identified the melanomas that led to the death of the patients.